Innovations in Implementing Medications for Opioid Use Disorder for HIV Prevention in Probation Settings in Eastern Europe

This K01 seeks support for formal coursework, seminars, interdisciplinary mentorship, and research in Eastern
Europe to expand the skills of a sociologist who has been academically productive in examining the social
production of HIV risk in prisons but now aims to shift their career toward tailoring implementation strategies for
HIV prevention among people who use drugs. Dr. Azbel seeks to broaden their training to emerge as an
independent researcher who can leverage newly acquired skills in ethnography, implementation science (both
theory and real-world experience), and mixed methods research and apply them to a new setting, probation,
which aligns with decarceration goals. They aim to shift their research trajectory from retrospectively unpacking
why an intervention did not work as expected (using qualitative interviews) to prospectively refining strategies to
improve interventions (using quantitative and ethnography). The training will support Dr. Azbel's two proposed
research projects, which use the EPIS framework to understand the influence of the inner and outer contexts on
the successful implementation of a screening-engagement-treatment (SET) strategy for opioid agonist therapy
(OAT) scale-up. The projects will occur in probation in Georgia and Moldova, two distinct epidemiological, social,
and geopolitical contexts. The conflicting roles of upholding public health and public safety strain the complex
and understudied officer-client relationship, which research has shown to be crucial for the successful
implementation of evidence-based practices. The core of these projects will be to refine strategies to align
probation officers’ primary focus (public safety by reducing crime) with their evolution toward public health
mandates (to reduce transmission of HIV through facilitating clients receiving OAT). Project 1.1, guided by the
socioecological model, will examine the barriers and facilitators within the inner context (officers and clients) to
implementing SET procedures to promote OAT scale-up using mixed methods, including structured surveys and
nominal group technique (NGT). Project 1.2 will use ethnographic methods to explore the dynamic interrelations
of the inner (client, officer) and outer (probation leadership, OAT clinics) contexts as SET is implemented and
process changes are introduced via NIATx (a bundle of implementation tools). The candidate will test the
hypothesis that NIATx improves collaboration and trust between probation staff, leadership, and clients,
particularly as their goals align as OAT improves individual health and reduces crime. These research aims will
be enhanced through the candidate getting certified as a NIATx coach where they will coach change teams in
probation in Kyrgyzstan. As probation services expand, including in the U.S., such analysis can be leveraged to
expand OAT as HIV prevention in ways that promote decarceration and are responsive to local needs and
contextual differences. The candidate’s long-term career goal is to become an independent global health
investigator focused on implementing culturally attuned HIV prevention interventions that target criminal justice
populations, especially where decarceration efforts are involved.

Public health relevance
Newly formed probation services in Eastern Europe, where the HIV epidemic continues to expand, provide a unique opportunity to reduce HIV transmission by linking people with opioid use disorder to opioid agonist therapy (OAT) while promoting decarceration efforts. Dr. Azbel's two proposed research aims use the EPIS framework to understand the influence of the inner (clients, officers, criminal subculture) and outer contexts (probation leadership and OAT clinic staff), as organizational process changes are introduced via NIATx, on the implementation of a screening-engagement-treatment (SET) strategy for OAT scale-up among probation clients in Georgia and Moldova. This K01 seeks support for enhanced coursework, seminars, interdisciplinary mentorship, and research experience to bolster the candidate’s ability to emerge as an independent researcher, leveraging newly acquired training in ethnography, implementation science, and mixed methods to inform implementation strategies of evidence-based HIV prevention practices in community supervision settings.